Training Program in Environmental Health Sciences

This is a renewal application for continued support of the longstanding (41th year), Johns Hopkins University
NIEHS Training Program in Environmental Health Sciences (EHETG), which has supported 57 current and
former predoctoral students and 19 current and former postdoctoral trainees over the last 10 years. The former
trainees are in research career positions in academia, government, and private health-related industry, while 15
predoctoral and 3 postdoctoral trainees are currently in training. Current and former trainees have published over
168 peer-reviewed scientific papers during their training. To achieve the mission of the NIEHS of discovering
how the environmental affects people in order to promote healthier lives, there is a critical need to prepare future
scientists to address the complex current and future pressing environmental health challenges. Thus, the goal
of this T32 is to provide the research foundation for predoctoral and postdoctoral scientists to become future
leaders of multidisciplinary research projects that seek to understand the role that environmental exposures play
in the etiology and exacerbation of human disease and apply this knowledge to develop prevention and
intervention strategies. The EHETG training program is uniquely situated to make important contributions by
being anchored within the dynamic, collaborative atmosphere at the Johns Hopkins Bloomberg School of Public
Health (BSPH) and has received significant institutional support for the program, that has greatly enhanced the
training mission. Our multi-disciplinary mentoring team (27) derived from multiple departments across BSPH (3)
and the Johns Hopkins School of Medicine (2) has substantial funding that provides a wealth of opportunities for
original research by both pre- and postdoctoral trainees. Our predoctoral trainees will participate in: 1) a rigorous,
core curriculum in environmental health sciences that provides the academic foundation for environmental health
scientists (epidemiologic methods, exposure sciences, toxicology, biostatistics and advanced data science
skills); 2) specialized innovative coursework in one of 3 focus areas (environmental exposures and environmental
epidemiology (ESSE); toxicology, physiology, molecular mechanisms (TPMM), and environmental sustainability,
resilience and health (ESRH) that support dissertation research; and 3) dissertation research. All trainees receive
instruction in the use of cutting-edge technologies, advanced data sciences, Responsible Conduct of Research,
grant writing, Research Communications, and have access to career development activities. The research being
conducted by the mentor-trainee teams address one or more of the following topics: (a) Defining the
environmental exposures linked to human disease; (b) Mechanisms of disease pathobiology; (c) Development
and application of biomarkers of pathobiology; (d) Determination of the health impacts and vulnerability of
populations to climate change; and (e) Development of intervention and mitigation strategies to create healthy
sustainable communities. In this renewal application, we request critical support for 3-4 pre-doctoral
students/year and 4 post-doctoral trainees/year for the Training Program in Environmental Health Sciences.

Public health relevance
This long-standing training program in Environmental Health Sciences at Johns Hopkins University provides state of the art training for the next generation of scientists in environmental sciences with the purpose of detection and evaluation of the health impacts of hazardous environmental agents on susceptible populations and the development of prevention/treatment strategies that will mitigate the impact of these exposures on human health.